The Florida Pediatric NCORP: NCI Community Oncology Research Program.

Project Summary
The Florida Pediatric NCORP is a consortium of five Florida pediatric hem/onc hospitals. The
NCORP geographically covers a large portion of Florida and provides pediatric oncology care to
the largest population centers in Florida, the third largest state in the country. The hospitals are
located in Ft. Myers, Hollywood, Orlando, and two sites inTampa, as well as the Central Office.
Over a 34 year period the Florida Pediatric CCOP, and since 2014, the Florida Pediatric NCORP
has been one of the single largest contributor of patients to COG treatment, cancer control, and
more recently, cancer care delivery studies. The CCOP, and now the NCORP, has consistently
had outstanding compliance scores and contributes to the administration and science of COG
through its members who chair or co-chair research base protocols. The goal of the Florida
Pediatric NCORP is to continue the ongoing effort to make available the latest advances in cancer
care to patients in Florida through participation in clinical trials and to register the majority of their
eligible patients on COG protocols, thereby providing quality care in patients’ home communities.
The Florida Pediatric NCORP provides a unique opportunity to study a geographically-defined
population to investigate risk factors, patterns of care, and population-based interventions. The
Florida Pediatric NCORP also maintains a Patient Log which affords the opportunity to ensure
the majority of eligible patients are registered on appropriate COG protocols. Over the last grant
cycle, the five Florida Pediatric NCORP participating sites have averaged over 420 patient
registration on COG treament, cancer control, and cancer care delivery protocols, as well as 500
biospeciem and special entries. The Florida Pediatric NCORP anticipates increased patient
registrations as more COG treatment, cancer control, and cancer care delivery protocols become
available. COG quality-control procedures will apply uniformly to the Florida Pediatric NCORP,
ensuring compliance with protocols and external review of pathology, radiotherapy, surgery, and
chemotherapy. The recent affilation with the Rochester Research Base will provide an opportunity
to particpate in available AYA trials.

Public health relevance
Project Narrative The Florida Pediatric NCORP will maintain its single focus to make the latest advances in cancer care available to large segments of Florida through participation in treatment, cancer control and CCDR trials through its affiliation with the Children’s Oncology Group (COG), and the University of Rochester Research Base (URCC).